Mechanisms for cellular copper import via secreted cuproproteins

Project Summary:
Copper is an essential micronutrient and a required redox-active cofactor for enzymes necessary for eukaryotic
respiration, oxidative stress resistance, and the production of functionalized cell signaling molecules. Very
recently, Cryptococcus neoformans Bim1 was reported to represent a new class of secreted and cell surface-
associated cuproproteins that promote fungal Cu-uptake via high-affinity CTR Cu-transporters during host
colonization. Homologs to C. neoformans Bim1 are highly represented in the genome of several fungal
pathogens affecting humans, and we identify this new family of Cu-scavenging proteins as Bim1-like proteins
(BLPs). Surprisingly, there is significant sequence diversity at the BLP active site and C-terminal GPI
anchoring domain. Virtually nothing is known on how such sequence variations affect Cu-trafficking function.
Our central hypothesis is that BLP active site variation is used to modulate Cu-binding affinity and oxidation
state specificity, whereas the C-terminal domain partitions BLP proteins at the cell surface. The overall goal of
this research project is two-fold: 1. To understand how the active site diversity within the BLP family affects Cu-
binding properties. 2. To understand how BLP extracellular localization patterns alter cellular Cu-homeostasis.
We propose to use the three BLPs encoded in the opportunistic fungal pathogen Pseudogymnoascus
destructans (Pd) as prototypes for the natural diversity of this new family of extracellular Cu-scavengers. We
will test our hypothesis in the following (2) specific research aims: Aim 1. To determine the impact of BLP
active site variation.; Aim 2. To define the role of Bim1-like protein (BLP) isoforms in extracellular Cu
trafficking. Under the first aim, we will (i) develop a recombinant expression platform to produce wild type and
variant PdBLPs. We will in (ii) determine how active site variation alters the metal-binding properties and the
copper coordination environment. Finally, in (iii) we will determine how active site variation alters Cu-redox
properties. In aim 2, we define the role of BLP isoforms in extracellular Cu trafficking. We will test the
innovative hypothesis that BLPs can partition at the cell surface to relay Cu to the cell surface and boost Cu-
import efficiency. To test this hypothesis, we will leverage the power of Saccharomyces cerevisiae (Sc)
genetics to build a model of the BLP/CTR uptake pathway. In (i-ii) we will optimize the recombinant expression
of PdCTR transporters and PdBLPs in S. cerevisiae. This will involve the rigorous characterization of protein
expression and localization patterns at the plasma membrane and cell wall. In (iii) we will assess the impact of
PdBLP expression levels and extracellular localization in facilitating Cu-import from diffusible and solid
supported Cu sources. The expected outcomes of this work are a basic understanding of how this novel BLP
Cu-uptake pathway functions to ensure adequate delivery of Cu-atoms to fungal pathogens under extremes in
copper bioavailability, akin to that found during host infection.

Public health relevance
Public Health Statement: Bim1 is linked to increased virulence for Cryptococcus neoformans in a mouse meningitis infection model and participates in Cu-homeostasis. Related BLP genes are also present in several fungal pathogens affecting humans, including Coccidioides immitis, Histoplasma capsulatum, Talaromyces marneffei, and Aspergillus niger but little is known about how BLP sequence variation affects biological function. In the proposed research project, we will explore the active site design of this novel class of BLP copper trafficking proteins and explore their mechanism for Cu-delivery at the fungal cell surface; ultimately our findings will lead to a deeper understanding of the mechanisms of copper homeostasis in fungi which may be exploited for the development of future antifungal treatment strategies.